PHASE I/II STUDY TO EVALUATE SAFETY, TOXICITY &EFFICACY OF 3TC, ZDV, DDI IN HIV

The purpose of this study is to evaluate the safety, toxicity and preliminary effectiveness of combinations of Lamivudine(3TC), Zidovudine(ZDV), and Didanosine(DDI) in children with HIV infection. Subjects will have a diagnosis of HIV infection (asymptomatic or symptomatic). Subjects will be seen and physically examined prior to study entry and at each scheduled study visit.